Identify Mechanisms Driving Resistance to AR Antagonists in CRPC

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PCa) that recurs after standard androgen deprivation therapy (ADT) with a GnRH agonist or
antagonist (castration-resistant prostate cancer, CRPC) is in most cases still dependent on androgen receptor
(AR). AR activity in these patients can be further suppressed by agents such as abiraterone or by AR antagonists
such as enzalutamide (ENZ), apalutamide, or darolutamide, but patients treated with these androgen signaling
inhibitor (ASI) drugs still invariably progress. A subset of tumors that progress despite ADT combined with ASI
drugs become AR independent, but the majority continue to have high levels of AR and AR transcriptional
activity. Therefore, a major focus of our efforts has been to determine the basis for this persistent AR activity.
Our approach during the current P01 funding period has been to trace the progression to ENZ-resistance in
VCaP cells, which express a wild-type amplified AR. ENZ treatment initially suppresses AR activity and
proliferation, but these cells adapt over 1-2 months with restoration of AR activity despite culture in 16 µM ENZ
(VCaP16 cells). Notably, AR activity in these cells is driven by an AR splice variant 7 (ARv7, the most common
AR splice variant), and is not dependent on the full length AR (ARfl). Moreover, we find that ARv7 activity is
dependent on adaptations that enhance chromatin accessibility. Sites with increased chromatin accessibility
were strongly associated with binding sites for the NFI family of transcription factors, and NFI depletion
decreased ARv7 chromatin binding and mimicked the effects of ARv7 depletion on the transcriptome. Aim 1 is
to test the hypothesis that NFI transcription factors are major contributors to establishing and maintaining the AR
cistrome and transcriptome, and to ENZ-resistance. In the ENZ-resistant VCaP16 cells we further found that
FOXA1 binding was increased at ARv7 binding sites, and by mass spectrometry identified increased
phosphorylation at sites that may enhance nucleosome binding. These findings are pursued in Aim 2. Aim 3 then
focuses on identification of additional adaptations that are required to support reactivation of the AR
transcriptional program in response to AR targeted therapies. The specific aims are 1) to determine the role of
NFI transcription factors in PCa progression and ARv7 function, 2) to determine the role of FOXA1
posttranslational modifications in supporting ARv7 function, and 3) to identify further adaptations that are critical
to support ARv7 function. This project makes extensive use of the PDX models and expertise in Core B and the
genomic capabilities and expertise in Core C. Moreover, our focus on how AR activity at all or subsets of genes
is highly related to the fundamental question addressed in Project 1, which is asking what are the critical functions
of AR in PCa. We will also have extensive interactions with Project 3, which will address the role of PARP in
ARv7 functions. Finally, our use of shared models and real-time sharing of data (facilitated by Core A) has during
the current funding cycle (and will continue to) lead to novel insights and new approaches and directions.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PCa) that recurs after available androgen receptor (AR) targeted therapies (castration- resistant PCa, CRPC) is in most cases still dependent on AR, with increasing evidence supporting a role for an AR splice variant (ARv7) in driving AR activity. Our findings indicate that ARv7 activity is dependent on adaptations that increase chromatin accessibility and enhance its interaction with chromatin, which may involve FOXA1 and NFI transcription factors. The aims are to pursue these or additional mechanism that drive persistent AR activity in CRPC.